The Primary Care Rural and Frontier Clinical Trials Innovation Center (PRaCTICe)

ABSTRACT
The Primary Care Rural and Frontier Clinical Trials Innovation Center to Advance Health Equity
(PRaCTICE) Network Research Hub (NRH) is a partnership between the Oregon Rural Practice-based
Research Network (ORPRN), the WWAMI (Washington, Wyoming, Alaska, Montana, and Idaho) region
Practice and Research Network (WPRN) and their institutions’ Clinical and Translational Science Award
(CTSA) programs. The PRaCTICE team has over two decades of experience partnering with 308 clinics
and communities in rural and low-resourced settings on research, education, and technical assistance
projects – including nearly 100 clinical research studies since 2019 (65 completed, 33 active). While 29%
(932/3160) of the census tracks across the six Western states are in rural designated locations (RUCA 4-
10), 76% of the priority year 1 clinical sites (N=29 clinics) we partner with in PRaCTICE are rural.
PRaCTICE will be co-led by the Directors of ORPRN and WPRN, strengthen established partnerships with
clinical sites in rural settings, and consists of four cores: Community Engagement, Recruitment & Trials,
Data Coordination, and Communications & Dissemination. Together these cores will work to successfully
accrue participants for existing primary care-based NIH studies and codesign future studies relevant to
primary care clinics and communities in rural and underserved settings. Notably, our approach builds on
established processes to support study codesign and infrastructure that extends beyond individual projects.
PRaCTICE is anticipated to have a substantial positive impact in adopting and implementing research
advances into clinical care, growing primary care engagement, and advancing health equity for rural and
other underserved communities.